Project 2: Innate Immune Pathways in Food-induced Anaphylaxis

SUMMARY – Project 2
Food allergy is mediated by IgE triggering of mast cells and basophils. We found that peanut-specific IgE and
basophil activation test could distinguish allergic from sensitized individuals, but had no utility in predicting
reaction severity during double blind placebo controlled food challenges (DBPCFC). Distinguishing mild from
potentially severe reactions would be of major clinical benefit. Transcriptional profiling identified a neutrophil
signature that was associated not only with reactions to peanut, but also with severity of reactions. Flow
cytometry profiling identified a significant increase in circulating neutrophils post-challenge, and preliminary
data shows a change in neutrophil phenotype consistent with activation. Although neutrophils have been
shown to be activated by IgG-allergen complexes, it is unlikely that there would be significant immune complex
formation due to the low dose of peanut exposure. Neutrophils have been shown to be responsive to serotonin
metabolites, and in preliminary data we demonstrate that activation of whole blood with peanut induces
serotonin release. Human mast cells (and potentially basophils) produce low levels of serotonin, but platelets
are a major source of serotonin in the circulation and can release it upon activation. We have previously shown
that platelets form complexes with basophils in blood from peanut allergic individuals upon exposure to peanut.
We hypothesize that basophil-platelet complexes are responsible for the release of serotonin, which then
activates neutrophils in the context of food allergy. We will test this hypothesis with three specific aims. The
first aim will use spectral flow cytometry and RNA sequencing to examine neutrophil and other innate immune
activation during DBPCFC. The second aim will examine the release of serotonin and serotonin metabolites
during reactions and test the role of serotonin and metabolites in neutrophil activation. The third aim will
examine the contribution of basophil platelet complexes to the production of serotonin in response to peanut
exposure. Successful completion of these aims will reveal novel innate immune mechanisms of severe
reactions to peanut, leading the way to new interventions for the prevention of severe peanut allergy.